Timing of Neuronal Chloride Uptake for Control of Neonatal Seizure

Project Summary and Abstract
Neuronal chloride concentration ([Cl-]i) is an important determinant of both post-synaptic GABAA-
receptor mediated signaling and cell volume regulation. After injury, neurons swell by admitting water
and chloride salts. The chloride moiety alters the reversal potential for GABA signaling, compromising
inhibition and contributing to early anticonvulsant-resistant seizures that are thought to worsen long-
term outcomes. An important pathway for neuronal entry of water and chloride salts are the reversible
cation-Cl- cotransporters (CCC) NKCC1 and KCC2. We hypothesize that emergent limitation of
neuronal chloride influx after recovery from hypoxia-ischemia by antagonizing NKCC1 activity and/or
KCC2 activity is a uniquely effective therapeutic strategy to reduce acute cell swelling and [Cl-]i
elevation in injured neurons, restore GABAergic inhibition, prevent chronic [Cl-]i elevation, recurrent
seizures and epileptogenesis. We will test these hypotheses in vitro and in vivo using established
models of hypoxic ischemic injury, transgenic chloride imaging, and multiphoton microscopy. The
overall goal of this project is to elucidate the progressive role of cation-chloride transport activity in
hypoxia-ischemia induced neuronal injury and seizures. The results will have an important positive
impact immediately because they will identify an optimal therapeutic window for prevention and
treatment of recurrent seizures in newborns that have suffered hypoxia-ischemia and are at high risk
for developing anticonvulsant resistant seizures, epilepsy, cerebral palsy and neuromotor disabilities.

Public health relevance
Project Narrative Recurrent seizures are the most common manifestation of an acute brain insult in neonates and children and are often resistant to antiepileptic drugs that target inhibitory chloride permeable GABAA receptors. It is well established that hypoxia-ischemia (HI) induces neuronal chloride elevation resulting in cytotoxic edema and recurrent seizures. Emergent prevention of neuronal chloride influx might reduce cell swelling, restore GABAergic inhibition, improve treatment and prevent seizures.